Nuclear receptors and their Coactivators as Mediators of Systems Metabolism

Overall -­ Project Summary

Obesity is approaching epidemic proportions as a nutritional and pathological disorder in the U.S. and is closely
associated with important syndromes including type 2 diabetes, insulin resistance, hepatic steatosis,
dyslipidemias, hypertension, coronary heart disease, osteoarthritis and cancer. Obesity rates in the U.S. have
continued to worsen whereby nearly 70% of the adult population is overweight and the yearly medical cost of
treatment for obesity-­related disease is estimated at $190 billion, currently 6X the annual NIH budget.
Consequently, obesity is anticipated to overtake smoking as the most preventable cause of adult mortality.
Therefore, public health initiatives focused on identifying therapeutic options to combat the detrimental effects of
obesity-­related disease rely on an improved understanding of how alterations in metabolic tissue crosstalk alters
metabolism to favor energy accretion and deposition. Our highly synergistic and integrated Program Project
team has identified previously unappreciated molecular mechanisms that highlight the coordinated actions of the
hypothalamus (brain), liver and white adipose tissues as gatekeepers of metabolic energy balance that become
dysregulated by overnutrition. By focusing on the metabolic actions of the Steroid Receptor Coactivator (SRC)
family as amplifiers of nuclear hormone receptor (NR)/transcription factor (TF) function in this triad of energy-­
responsive tissues, we have exposed transcriptional reprogramming as a key molecular determinant in the
disruption of normal energy homeostasis arising from chronic exposure to caloric excess. Such a complex
metabolic regulatory axis, which involves the interplay of multiple tissue systems (i.e. brain, liver, adipose), and
underlying transcriptional machinery (NR/SRCs) that maintain their homeostatic balance, can only be adequately
studied by a multidisciplinary research team with unique, yet synergistic, expertise. Leveraging the collaborative
framework of the NIDDK P01 Program Project, we have assembled such a team of scientists who are dedicated
to the overall objective of understanding the ‘mechanisms’ for the downstream tissue-­specific metabolic functions
of NR/SRC action that govern whole body energy balance.

Public health relevance
Overall - Project Narrative The proposed research is relevant to public health initiatives and to the overarching mission of the NIH and NIDDK as it seeks to improve our understanding of the transcriptional events that underlie the complex progression of metabolic disease through studying the coordinated actions of the brain, liver and fat. It is our expectation that expanding our knowledge of the transcriptional mechanisms that disrupt metabolic tissue function will be an important step in guiding the development of new therapeutics to treat obesity-driven diseases.